Testing a Biopsychosocial Model of Violence Exposure, Minority Stressors, and Hazardous Drinking among Sexual Minority Women

Project Summary/Abstract
Sexual minority women (SMW) are one of the highest-risk groups for posttraumatic stress disorder (PTSD),
hazardous drinking (HD), and comorbid PTSD and HD (PTSD-HD); disparities are heightened for those with
multiple minoritized identities. These disparities are rooted in SMW’s disproportionate and cumulative exposure
to sexual identity-specific and intersectional forms of stigma, trauma, and lack of safety. The self-medication
model posits that alcohol is often used to reduce distressing PTSD symptoms. Yet, few studies have tested the
temporal precedence of PTSD in HD development and maintenance, especially in SMW. Sensitization to
repeated psychosocial stressors may lower SMW’s threshold for tolerating distress, leading to persistent stress
reactivity and PTSD-HD risk. Single-session interventions (SSIs) with cognitive restructuring and exposure
components hold promise for addressing mechanisms (e.g., emotion regulation) underlying PTSD-HD and
broadening access to low-intensity treatments among SMW. The proposed research is within the scope of the
parent award, directly responds to NOT-OD-24-032, and advances addiction science by clarifying the long-
term effects of PTSD on HD, identifying biopsychosocial drivers of PTSD-HD, and guiding the initial adaption of
an SSI targeting cognitive reappraisal to mitigate stress reactivity, PTSD symptoms, and alcohol craving
among SMW. Specific aims are to: (1) examine prospective longitudinal associations between PTSD symptom
severity and cluster and HD among 515 SMW and determining for whom severe PTSD symptoms and specific
PTSD clusters may be linked to elevated HD levels 10 years later; (2) explore whether intersectional stigma
cues induce stress reactivity and assess variability in state PTSD symptom severity and alcohol craving in
response to intersectional stigma-related reactivity among 75 SMW; and (3) conduct formative interviews with
30 SMW and 5 Community Advisory Board members from Aim 2 about the acceptability, feasibility, and
improvement of an affirmative SSI focused on cognitive reappraisal and tailored to address personalized stress
cues for SMW with PTSD-HD. Findings will inform a future planned R01 to assess stress reactivity to stimulus-
specific cues, examine variations in state PTSD symptoms and alcohol craving based on stimulus-specific
stress reactivity, and formally adapt and pilot test a cognitive reappraisal-focused SSI representing the first
brief treatment providing potent, accessible strategies for reducing PTSD-HD in the context of salient cue
exposure among SMW. The timeliness of this supplement is supported by critical research gaps highlighted in
the proposal, federal funding priorities, and the

Public health relevance
Project Narrative Sexual minority women (SMW) are one of the highest-risk groups for posttraumatic stress disorder (PTSD), hazardous drinking (HD), and comorbid PTSD and HD (PTSD-HD) due to psychosocial stressors, including trauma, sexual identity-specific stigma, intersectional stigma, and persistent stress reactivity. Extant research is limited by a lack of studies on the temporal precedence of PTSD in HD development and maintenance, physiological stress reactivity to intersectional stigma and its role in elevating the risk of PTSD-HD, and the development of brief, tailored treatments for PTSD-HD among SMW. The proposed research aims to address these gaps by 1) examining prospective longitudinal associations between PTSD symptom severity and HD over 11 years; 2) assessing the acute effects of intersectional stigma exposure on alcohol craving and state PTSD symptoms through biological mechanisms; and 3) guided by ADAPT-ITT phases 1 and 2, conducting formative interviews with SMW and Community Advisory Board members to adapt an existing cognitive- behavioral therapy module focused on cognitive reappraisal into a single-session intervention to reduce stress reactivity, PTSD symptom severity, and alcohol craving within the context of cue reactivity paradigms in SMW.